Investigating the Protective Efficacy of SIV/HIV T and B cell Immunity Induced by RNA Replicons

ABSTRACT
The development of a prophylactic vaccine for HIV would benefit from the generation of immunogens and vaccine
delivery modalities that can induce a combination of highly functional CD8+ T cell responses towards mutation
constrained epitopes and broadly neutralizing antibody responses to the HIV envelope trimer. Thus, in this
proposal, we plan to leverage three components towards this goal: an approach known as structure-based
network analysis that was used to identify a set of protective epitopes preferentially targeted by CD8+ T cell
responses in spontaneous HIV controllers, 2) an envelope trimer that is capable of eliciting heterologous
neutralizing antibody responses and 3) and an innovative vaccine delivery platform of self-amplifying RNA
replicons that can elicit both robust CD8+ T cell and humoral immunity. Having applied structure-based network
analysis to SIV protein structures, we have already identified a set of mutation constrained (‘highly networked’)
SIV epitopes restricted by an array of Mamu class I alleles. In addition, we have also produced compelling data
demonstrating the ability of RNA replicons to induce CD8+ T cell responses to highly networked SIV epitopes
and strong trimer-specific antibody responses in rhesus macaques. What remains to be determined is whether
functional CD8+ T cell responses towards highly networked SIV epitopes have a protective benefit against
heterologous challenge, either individually or in tandem with antibodies. Thus, in Aim 1 of this proposal we will
assess the protective efficacy of a RNA replicon vaccine immunogen comprised of highly networked SIV epitopes
in a group of 20 rhesus macaques. These immunized macaques will be divided equally between those receiving
mock immunization or highly networked SIV epitope immunization (10 per group). Following immunization,
vaccine-induced CD8+ T cell responses directed against highly networked SIV epitopes will be assessed and
vaccinated animals would then be subjected to repeated low dose SHIV.BG505 challenge. These SHIV
challenged macaques will have viral load, CD4 count and CD8+ T cell phenotype assessments every 2 weeks
during the challenge period and for 20 weeks following the challenge period as well. Go/No-Go criteria regarding
T cell immunogenicity and the effects of vaccination on SHIV viral loads will be established and evaluated at the
end of year 2. In Aim 2, we will assess the immunogenicity and efficacy of a combined RNA replicon-based
vaccination with a highly networked SIV epitope immunogen and HIV Env trimer immunogen. These immunized
macaques will be divided equally between those receiving mock immunization, HIV Env trimer + mock
immunization and a combination of both HIV Env Trimer and highly networked SIV epitope immunogens (10 per
group). These studies will help determine whether vaccine-induced CD8+ T cell responses directed towards
highly networked epitopes can provide a protective benefit either individually or in combination with antibody-
based vaccination. Additionally, this work will provide critical support of the self-amplifying RNA replicon vaccine
delivery platforms towards the development of an effective, prophylactic HIV vaccine.

Public health relevance
PROJECT NARRATIVE There are currently 1.5 million new HIV infections each year. Thus, there is a great need to develop a safe and effective prophylactic HIV vaccine. In this application, we propose to evaluate an innovative algorithm to identify protective CD8+ T cell epitopes, HIV envelope trimer immunogens and a novel vaccine delivery platform of self- amplifying RNA replicons within the non-human primate model in order to further inform the components that are necessary to achieve a prophylactic vaccine for HIV.